Training Program/Rheumatic Diseases

Project Summary
The Training Program in Rheumatic Diseases has had a three-decade history of providing cutting edge training
physicians and scientists in the investigation of the pathophysiology, diagnosis, treatment, and outcomes of
rheumatic diseases. The Program is a collaborative effort between the Adult and Pediatric Divisions of
Rheumatology at The University Pennsylvania and The Children’s Hospital of Philadelphia along with The
University of Pennsylvania Biomedical Graduate Studies program, the Medical Scientist Training Program, and
the Graduate Medical Education programs of the Adult and Pediatric Rheumatology Divisions. The Program
offers a rich and diverse mentored environment for training in basic lab investigation, translational research,
clinical epidemiology, and bioinformatics and spans Immunology, Muscle and Bone Biology, and Clinical
Rheumatology knowledge domains. Our multi-disciplinary cohort of trainers come from the School of Medicine,
the Veterinary School, the Dental School, the School of Arts and Sciences, and the Wistar Institute and represent
multiple Departments and Divisions. Training is requested for 3 pre-doctoral and 3 post-doctoral positions. Pre-
doctoral trainees are recruited from students enrolled in The University of Pennsylvania’s highly competitive PhD
and MD/PhD programs in Biomedical Graduate Studies, and must complete rigorous didactic coursework as
well as careful thesis committee evaluation. Post-doctoral trainees are selected from the already highly
competitive and select pool of clinical fellows from both the Adult and Pediatric Rheumatology fellowship
programs as well as PhD scientists within the participating Schools investigating aspects of Rheumatic Disease.
Typical appointments are for 2 years, pending appropriate progress by the trainee. All trainees benefit from a
robust environment of colloquia, seminars, retreats, and lectures, and expected to contribute to this environment
through their own presentations and publications. Trainees are assessed using an Individualized Development
Plan that is reviewed by the trainee, mentor, and the PIs of this Program. The Program itself is continuously
evaluated by direct feedback from trainees and mentors, through annual review by an Internal Advisory Board
and an external consultant, and by self-study techniques. As a measure of success, this Program has
successfully trained a number of investigators now running their own independent NIH funded research
programs in Rheumatic Disease from both the pre- and post-doctoral training streams. In recognition of the rapid
expansion of technology and methodology that allows for the blurring of lines between bench and clinical
research, the Program has made particular emphasis in growing mentors and trainees in bioinformatics,
translational science, and other domains in order to position ourselves to continue our success in the
development of the future leaders of scientific inquiry into Rheumatic Disease.

Public health relevance
Project Narrative The Penn Training Program in Rheumatic Diseases will provide the infrastructure and outstanding opportunities required to develop the next generation of physicians and scientists prepared to address the need to continue to close our knowledge gaps about basic pathophysiology, diagnosis, epidemiology, outcomes, and treatment of rheumatic diseases in all their manifestations. The program’s goal is to provide a rich, multi-disciplinary, multi- modal training environment to support the success of developing trainees in becoming independent scientists dedicated research in Rheumatic Disease. This program builds upon many decades of excellent success by the Penn/CHOP Adult and Pediatric Rheumatology Divisions in training leading researchers in Rheumatology.